Structure and function of mGluR3 interactions with beta-arrestins and the membrane.

PROJECT SUMMARY
This proposal contains a comprehensive program to support a transition toward an independent research career
focused on understanding how membrane protein function is modulated by interactions with other proteins and
phospholipid membranes, and how this modulation impacts cellular processes and is altered in disease-states.
This application describes an innovative and ambitious proposal directly tied to my career and training goals.
Background: G protein-coupled receptors (GPCR) are membrane proteins that sense extracelluar stimuli and
initiate intracellular signaling pathways through interactions with cytosolic G proteins. Classically, GPCRs are
thought to undergo a multi-step inactivation and desensitization process via interactions with β-arrestins following
hyper-phosphorylation of the intrinsically-disordered GPCR C-terminal domain (CTD). β-arrestins can also
initiate distinct signaling cascades in addition to desensitizing and internalizing GPCRs, though the molecular
determinants for each pathway are not well understood. This system is further complicated by the presence of
two β-arrestin isoforms which are thought to prefer different GPCR CTD phosphorylation patterns and may
initiate different cellular pathways. Metabotropic glutamate receptors (mGluR) are dimeric, neuronal GPCRs that
are responsible for sensing main excitatory neurotransmitter glutamate both pre- and post-synaptically. Recently
a single isoform, mGluR3, was identified to undergo robust β-arrestin-mediated internalization and the β-arrestin-
binding region of the CTD was identified. This was the first reported interaction between a dimeric GPCR and β-
arrestins, leading to novel questions about complex stoichiometry and structure. This mGluR3-β-arrestin
interaction is further complicated by preliminary data indicating that the β-arrestin binding region of the mGluR3
CTD also interacts with the phospholipid membrane. Specific Aims and Research Design: The proposed study
investigates the interactions between mGluR3 and both β-arrestins and the membrane using a combination of
1) single-molecule and ensemble fluorescence-based binding methods to investigate the determinants of the
formation of mGluR3-β-arrestin complexes, and 2) cryo-electron microscopy and nuclear magnetic resonance
spectroscopy to assess the structural features of interactions between mGluR3, β-arrestins, and the membrane.
My in vitro and structural findings will be validated using cellular assays and imaging. Findings will inform a
K99/R00 proposal aimed to apply the approaches and findings from this F32 research program broadly to other
GPCRs and to pursue the functional consequences of GPCR-β-arrestin coupling in in vivo models. Training
and Mentoring: Training goals are supported by 1) a team of co-sponsors Drs. Levitz and Eliezer and a close
collaborator (Dr. Meyerson) with expertise in biophysical and biochemical research, 2) a rich institutional
environment at Weill Cornell Medical College, and 3) scientific meetings, seminars, and planned publications.
Impact: The experience gained during this award will serve at the foundation for my independent career as a
protein biophysics researcher and for the development of a novel program of membrane protein research.

Public health relevance
PROJECT NARRATIVE Desensitization and internalization of G protein-coupled receptors (GPCR) by β-arrestins is required for regulating cellular responses to extracellular stimuli (i.e. neurotransmitters) and relies on the differential phosphorylation of the GPCR. The proposed project aims to use a combination of structural, biophysical, and cell-based approaches to investigate the determinants and stoichiometry of the interaction between a dimeric GPCR (mGluR3), β- arrestins, and lipid membranes. This study is essential to increase our understanding about how GPCR function is regulated by β-arrestins and to develop novel experimental assays to measure interactions between soluble and membrane-embedded proteins.